Preclinical validation of mGlu2 PAMs in alcohol use disorder

PROJECT SUMMARY
Alcohol Use Disorder (AUD) continues to be a significant problem, affecting 28.3 million adults in the United
States, and is the third leading preventable cause of death. Disulfiram, naltrexone, and acamprosate are the only
drugs approved by the Food and Drug Administration, but all three have limited efficacy and several
contraindications. Given the substantial burden on society and the economy ($249 billion in 2010), there is a
clear unmet need for effective and well-tolerated therapies that reduce alcohol dependence and relapse in AUD
patients. AUD is characterized by phases of binge drinking, intoxication, and negative emotional states during
withdrawal. The anticipation of alcohol leads to a repetition of these phases followed by periods of extended
abstinence and frequent relapse. Importantly, each of these phases is accompanied by sleep disturbances (SDs).
Three primary brain regions are involved in AUD-associated behavior: the prefrontal cortex (anticipation), basal
ganglia (binge drinking), and amygdala (withdrawal). Several neurotransmitters are dysregulated in AUD,
including the glutamatergic system. Extensive experimental evidence suggests that glutamate (Glu) critically
modulates the actions of drugs of misuse, including alcohol. Therefore, normalization of aberrant Glu activity
caused by chronic alcohol use potentially represents a novel therapeutic strategy to prevent relapse in AUD. The
activation of metabotropic Glu receptor subtypes 2 and 3 (mGlu2/3) using agonists or positive allosteric
modulators (PAMs) decreases ethanol (EtOH) self-administration (SA) as well as cue-induced reinstatement of
EtOH seeking in rodents. Both alcohol-dependent rodents and humans show downregulation of mGlu2
expression, and many studies suggest that deficiencies in mGlu2 signaling may underlie AUD pathology.
Moreover, preclinical studies indicate that mGlu2/3 activation has promise for treating stress- and anxiety-related
disorders in humans and can systematically augment sleep, symptoms that are comorbid with AUD. We
hypothesize that mGlu2 PAMs represent a promising new class of drugs to treat AUD. To test this hypothesis,
our team has discovered and optimized three small molecule mGlu2 PAMs, SBP-9330, SBP-1315, and
SBP-9220, that show efficacy in multiple models of substance-use disorders. To accomplish this, our specific
aims are (1) Determine the in vivo efficacy of mGlu2 PAMs to decrease EtOH intake in rat models of dependent
and non-dependent EtOH SA, (2) Determine the in vivo efficacy of mGlu2 PAMs to normalize SDs during
withdrawal and abstinence following EtOH SA, and (3) Determine the effect of a fixed dose of EtOH on the PK
profile and maximum tolerated dose of mGlu2 PAMs in rats. We have assembled a multidisciplinary team of
investigators with the expertise and experience to achieve these outcomes. Successful completion of these
studies will facilitate the development of a novel mGlu2 PAM towards filing of an investigational new drug (IND)
application and ultimately, a safe and effective treatment for AUD.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder (AUD) is a significant problem in the United States with limited treatment options to reduce alcohol dependence and relapse. Based on the localization and signal transduction mechanism of metabotropic glutamate 2 (mGlu2) receptors, there is a strong rationale that positive allosteric modulators (PAMs) of mGlu2 will effectively treat multiple symptoms that contribute to alcohol dependence and relapse, including attenuation of ethanol self-administration and sleep disturbances. The overarching goal of this application is to assess the potential of mGlu2 PAMs as a novel pharmacological treatment for AUD.